HIV Clinical Tumor Biorepository

Abstract: The HCTB Core will assist Junior Principal Investigators (JPIs) with the application of their
promising research to the field of clinical viral oncology through prioritization of clinical data and biospecimen
collection for JPIs in Phase 2 of Center for Translational Viral Oncology (CTVO). The CTVO will support
personnel in the Core who will provide services to the JPIs at reduced/no cost. Consistent with the articulated
theme of Phase 2 CTVO, the HCTB, organized and directed by Drs. Subbiah and Bonstaff, collects
biospecimens from the HIV/AIDS Malignancy Program and from other oncology clinics that evaluate,
diagnose and treat patients with viral associated malignancies. These patients are disproportionately
minorities, mostly African American. The overarching goal of HCTB is to assist JPIs with performance of
high-quality translational research utilizing linked biospecimens and clinical data from patients receiving care
at the University Medical Center - Infectious Diseases Center (UMCNO-IDC) and its affiliated partner,
HIV/AIDS Malignancy Program. Use of de-identified human samples will inform and ensure clinical relevance
of mechanistic studies and promote clinical translation. Through this effort, we seek to improve health
outcomes for underserved HIV+ patients at risk for virus-associated cancers. In addition, access to these
unique samples provides JPI's with a competitive edge as they apply for independent grant funding. The
HCTB Core will support proposed by JPI research through the following Specific Aims: 1) To expand a HIV
outpatient clinic-based system for collection of linked clinical data and biospecimens from HIV+ patients in
New Orleans who are at high risk for virus-associated cancers; 2) To ensure storage of high-quality HIV+
biospecimens for easy access by JPIs; 3) To perform timely delivery/shipment of HIV+ biospecimens to
internal and external collaborators; 4) To promote collaboration between JPIs and the staff of the Louisiana
Tumor Registry (LTR) at LSU School of Public Health to provide access to updated epidemiologic data and
analyses on the distribution of viral tumors in underserved minority populations in our State. Funding to the
CTVO will support personnel employed within the Core and allow services to be provided at reduced cost to
the JPIs while also providing for institutional ethical compliance and insuring protection of human subjects
and their privacy. Leveraging involvement of several Centers and Programs at LSUHSC ensures ongoing
support and function of this Core following conclusion of the COBRE funding.